Cortical odor processing for social recognition

PROJECT SUMMARY
The sense of olfaction allows animals to gather critical information about resources, dangers, and potential social
interactions. A primary goal of olfactory neuroscience is to understand how neural circuit operations in the main
olfactory system parse chemical signals in the environment and contribute to adaptive behavior. Neural circuits
in piriform cortex (PCx), the primary olfactory cortex, are thought to transform elemental odor information
received from the olfactory bulb into more holistic ‘odor object’ representations that signal the presence of unique
odor sources in the environment. The olfactory system developed this ability over the course of evolution in
contexts where information about the presence and identity of other animals, especially conspecifics, was
critically important. Substantial progress has been made in understanding representations of neutral
monomolecular odorants in PCx. By contrast, nothing is known about olfactory cortical processing of social
scents. In support of a specialized role in social odor processing, PCx densely expresses receptors for the
neuropeptide oxytocin (OT) involved in a wide range of social behaviors. However, the potential for OT
modulation also suggests that PCx circuits may operate differently in social and nonsocial contexts. The objective
of this proposal is to understand how cortical odor processing contributes to social behavior. The central
hypothesis is that OT modulates PCx circuit dynamics in social contexts to allow distinct conspecific identity
coding and support social recognition. The approach is to use calcium imaging and multi-electrode recordings
to observe PCx population responses during social odor processing and to use targeted perturbations of PCx
function to test its role in social behavior. The rationale is that observing and perturbing the system as it performs
its natural role in an adaptive behavior provides the most accurate picture of PCx’s capabilities and contribution
to fitness. The following aims address these goals: Aim 1: Determine how social recognition information is
encoded in piriform cortex. We will image large populations of PCx neurons in freely interacting animals and
compare dynamics and coding properties during social or nonsocial stimulus investigation to test our hypothesis
that distinct circuit dynamics in social contexts enable reliable discrimination of individual social identity. Aim 2:
Determine how oxytocin modulates social odor processing in piriform cortex. We will first measure
dynamics of OT neuron activity during social interactions using fiber photometry, and then match these dynamics
with optogenetic stimulation of OT neurons while recording PCx population responses to controlled presentation
of social odors. Aim 3: Determine the role of piriform cortex in individualized social behavior. PCx function
will be perturbed by chemogenetic inactivation or by deletion of OT receptors to test whether cortical processing
and modulation are required for social interactions that depend on identifying individual social partners in
pairwise and group settings. This work will provide fundamental insights into how the olfactory system contributes
to adaptive behavior in natural contexts.

Public health relevance
PROJECT NARRATIVE Social recognition is essential for navigating human relationships, and impairments in this ability contribute significantly to difficulties faced by patients with neurodevelopmental and neurodegenerative disorders such as autism spectrum disorder and dementia. This research addresses how cortical processing organizes sensory information that distinguishes individuals, a prerequisite for making behavioral decisions in social groups, and thereby makes a fundamental contribution to our broader understanding of brain mechanisms that enable social behavior. Moreover, this work lays a foundation for intensive investigations of olfactory processing of natural stimuli, with the promise of significantly increasing the biological relevance of our insights and, by extension, the translational relevance of our work for patients with olfactory dysfunction.